Structure and Function of Biosynthetic Enzymes

DESCRIPTION (provided by applicant): Thousands of terpenoid derivatives found throughout Nature are involved in diverse biosynthetic and metabolic pathways such as cholesterol biosynthesis in humans and menthol biosynthesis in mint. Notably, many terpenoids have been used as medicinal agents since the times of antiquity due to their analgesic, antibiotic, and antifungal properties. In spite of the universal importance of this family of natural products for human health, the three-dimensional structures of terpenoid cyclases have only been reported relatively recently; the majority of these structure determinations have been supported by GM56838. Terpenoid cyclases (a.k.a. terpene synthases) catalyze the cyclization of a common allylic pyrophosphate substrate, such as farnesyl diphosphate, to form one of hundreds of possible products. The terpenoid cyclase plays a critical role as a template in chaperoning substrate and intermediate conformations. The cyclization reaction can be very specific and lead to the formation of one exclusive product, or it can be somewhat promiscuous and lead to the formation of several products. Thus, the terpenoid cyclases comprise an exciting class of biosynthetic enzymes from both the biological and the chemical perspectives. In the current funding period, we have determined the X-ray crystal structures of the sesquiterpene cyclases A. terreus aristolochene synthase, delta-cadinene synthase, and epi-isozizaene synthase; we have established the structural basis for aberrant product formation by wild-type trichodiene synthase and its site-specific mutants; and we have generated the first crystals of a diterpene cyclase, copalyl diphosphate synthase. We aim to build upon this outstanding structural foundation in the next funding period by dissecting detailed structure-function relationships in aristolochene synthase and epi-isozizaene synthase to better understand the structural basis of biosynthetic diversity. Specifically, we will study site- specific variants engineered to generate alternative products, and we will develop a structure-based approach for generating new cyclic terpenoids in protein engineering experiments. Additionally, we will determine the X-ray crystal structures of copalyl diphosphate synthase and geosmin synthase to explore the evolution of domain architecture in multidomain terpenoid cyclases. These studies will illuminate the evolutionary roots of biosynthetic diversity in the greater family of terpenoid synthases. PUBLIC HEALTH RELEVANCE: Structural and functional studies of the terpenoid cyclases show how these novel enzymes generate the largest and most diverse family of natural products found on the Earth. Importantly, many terpenoids exhibit useful medicinal properties, e.g., as antibacterial, antifungal, anti-inflammatory, or anticancer agents. Therefore, understanding and engineering terpenoid cyclase function in generating complex carbon scaffolds with great specificity and efficiency will ultimately enable drug discovery at the interface of synthetic chemistry and synthetic biology.

Public health relevance
Structural and functional studies of the terpenoid cyclases show how these novel enzymes generate the largest and most diverse family of natural products found on the Earth. Importantly, many terpenoids exhibit useful medicinal properties, e.g., as antibacterial, antifungal, anti-inflammatory, or anticancer agents. Therefore, understanding and engineering terpenoid cyclase function in generating complex carbon scaffolds with great specificity and efficiency will ultimately enable drug discovery at the interface of synthetic chemistry and synthetic biology.